Targeting Health Disparities through Housing Redevelopment: A Natural Experiment of Housing Quality, Stability, and Economic Integration

PROJECT ABSTRACT
Community redevelopment policies that aim to move families from communities of concentrated poverty into
mixed-income communities have the potential to positively transform the lives of those families, reducing
barriers and providing opportunities for sustained upward social mobility and better health outcomes. However,
transitions into mixed-income communities are not without challenges, including the potential for highlighting
economic inequality and increasing exposure to discrimination and social exclusion, especially among youth of
color (e.g., Chaskin et al., 2013; Odgers & Adler, 2018) and older youth. This Diversity Supplement presents a
unique opportunity to examine whether improvements in academic or health outcomes following a transition
into high quality, mixed-income housing are mediated by shifts in social mobility beliefs which then help youth
better take advantage of new social connections and opportunities in their mixed-income community. Aim 1:
Use mixed methods to track whether beliefs about social mobility shift in response to changes in housing and
community contexts, and whether these shifts vary by age. Aim 2: Examine whether changing housing and
community contexts affect academic and health outcomes by shifting beliefs about social mobility. Aim 3:
Assess whether the consequences of social mobility beliefs vary based on racial-ethnic identity. Clarifying the
mechanisms that affect why and for whom benefits accrue is essential for creating better community
redevelopment policies and improving opportunities for economic mobility.

Public health relevance
PROJECT NARRATIVE The proposed study aims to examine whether improvements in the academic or health outcomes of youth following a transition into high quality, mixed-income housing are mediated by shifts in social mobility beliefs, and whether these relations vary with age or racial-ethnic background. Results from this study will clarify a mechanism by which community redevelopment policies create opportunities for academic and health benefits and provide important information about who benefits most from these types of policies.